The Influence of Vocal Loading Upon the Healing of Experimental Vocal Fold Injury

Project Summary
The development and maintenance of a speaking and singing fundamental frequency, while also achieving vocal clarity
throughout life, are important public health concerns. Symptoms of dysphonia are among the most common communication
disorders. Currently there is no treatment to restore a native vocal fold lamina propria composition or laryngeal movements
after injury. Research is limited because there is no in vivo model for larynx injuries that express a vocal behavior that can
serve as a reliable phenotypic marker. In general, an animal model can benefit research if its behavior can serve as marker
for the onset or the time-course of a pathology affecting a complex behavior. Specifically, the availability of an animal
model that combines experimental and genetic accessibility with important similarities to human voice production could
allow stronger inferences. Here we propose (1) to quantify key anatomical features of the vocal organ during postnatal
developmental in a new model, and (2) to describe the time-course of wound healing after experimental vocal fold injury in
a vocal dose- dependent fashion. Results will be integrated in a computational vocal fold model. Completion of this work
will provide the field with a new mouse model for the study of vocal disease mechanisms and therapeutic development. It
will also inform the role of vocal occupancy on the healing process of vocal folds.

Public health relevance
Project Narrative The mechanisms and timing of normal postnatal development of the lamina propria, and its re-modeling after injury in a vocal dose-dependent manner, will be explored in a new mouse model for voice research.